Insula-amygdala circuits in alcohol abuse

PROJECT SUMMARY
Alcohol use disorder (AUD) may result from profound dysregulations of affective valence
processing in brain circuits. Repeated episodes of binge drinking can alter positive and negative valence
processing and result in enhanced appetitive drives to seek and drink alcohol and the emergence of
aversive symptoms, respectively. This research proposal aims to understand how repeated binge drinking
alters neural coding and plasticity correlated with behavioral changes in the basolateral amygdala (BLA), a
well-known brain area for valence coding, and its afferents from the anterior insular cortex (aIC), a core area
for interoception. These aims will be empirically pursued using a combination of an alcohol operant self-
administration paradigm, behavioral assays for anxiety measurement, and a “drinking-in-the-dark”
procedure. Here, experiments will functionally and molecularly identify neuronal populations within the aIC-
BLA circuits that participate in alcohol drinking and determine how repeated binge drinking affects these
neurons and leads to maladaptive affective behavior, such as enhanced alcohol seeking and anxiety-like
behavior.
Supported by preliminary data, our central hypothesis is that repeated binge drinking differentially
alters the activity of valence coding amygdala neurons (Thy1+), in part, through the synaptic plasticity of
aIC-amygdala projections, resulting in alcohol-related enhanced appetitive and aversive behavior. Aim one
will use in vivo calcium imaging and optogenetic approaches to determine the role of BLA valence coding in
repeated binge drinking-induced behavioral plasticity. In the second aim, we plan to investigate synaptic
plasticity in the aIC afferents to the BLA valance coding neurons that contribute to the persistent motivation
for alcohol intake after repeated episodes of binge alcohol drinking. This work will uncover changes in
overlapping, intersecting or parallel valence coding systems in the aIC-BLA circuits that are critical for the
development of maladaptive affective behaviors by repeated excessive alcohol drinking. The proposed
experimental work portrays a neural circuit-oriented and highly translational investigation of AUD-associated
symptoms.

Public health relevance
PROJECT NARRATIVE The proposed research aims to discover critical neural correlates resulting from repeated excessive alcohol drinking that may progressively lead to the allostatic state. We focus specifically on neuronal plasticity associated with the development of maladaptive affective behaviors caused by repeated binge drinking. We will determine how dysfunctions in valence coding amygdala neurons and projections from anterior insular cortex to these neurons contribute these behaviors, and we seek to identify circuit-based novel targets for more effective treatment of AUD.